A Patient-Caregiver Behavioral Intervention for Older Adults with Cancer and Mild Cognitive Impairment

Project Summary/Abstract: This proposal presents a five-year research career development program focused
on the study and development of a dyadic behavioral intervention to improve distress (e.g., depression and
anxiety) and communication for older adults coping with cancer and pre-existing mild cognitive impairment (MCI);
and for their family caregiver. While MCI in older adults does not overtly impede function, it can manifest under
conditions of distress. Close to 50% of older adults with co-occurring cancer and MCI are at vulnerable risk to
experience high levels of distress (e.g., depression and anxiety) which can negatively affect their sense of
independence, communication of what matters most for their care, and overall quality of life. Their family
caregivers may experience equal or even higher levels of distress when managing their loved one’s cancer
symptoms and cognitive deficits. Surprisingly, a large gap exists in the development of dyadic behavioral
interventions to treat distress and improve communication to address both patient and caregiver needs. The
proposed project seeks to address a major gap in the literature and clinical practice for older adults with co-
occurring cancer and MCI, and their family caregiver. The overall objective of this K08 proposal is to develop a
dyadic intervention (created by Dr. Ramos, titled: COPE+), informed by her previous work in individually based
interventions for oncology and palliative care populations, and pilot COPE+ as a novel patient-caregiver dyadic
intervention consisting of distress coping skills, and newly include communication-skills training. The proposed
mentored research activities for this K08 award are to refine and pilot test the dyadic intervention informed by
Family Self-Management Theory. Mentored research training will occur in the context of a focused research
project with three aims: 1) To refine the COPE+ intervention using interviews with patients, caregivers and
providers. 2) To finalize the intervention and study procedures through user testing. 3) To examine the feasibility
and acceptability of COPE+. This K08 application is consistent with NCI’s mission to advance scientific
knowledge of the unique needs of people living with cancer and aligns with the NCI’s Division of Cancer Control
and Population Sciences in helping reduce the burden of the cancer experience via use of behavioral intervention
approaches to enhance quality of life. To become an independent researcher in the field of geriatric oncology
and mental health, Dr. Ramos requires additional training in: 1) qualitative research and geriatric oncology; 2)
recruitment, engagement, and retention of older adults with cancer and MCI, and their family caregivers; 3)
design, develop, and pilot dyadic behavioral interventions; and 4) develop expertise in dissemination and
implementation. Dr. Ramos’ intensive training plan coupled with a team of internationally recognized researchers
in health psychology, geriatrics, health services/implementation science, underrepresented faculty development,
and biostatistics will position her to be a geropsychology leader studying and addressing mental health in older
adult cancer populations and co-occurring MCI.

Public health relevance
Project Narrative: Distress (e.g., depression and anxiety symptoms) in older adults with cancer and mild cognitive impairment (MCI) represent a significant public health burden for them and their caregivers in terms of impaired quality of life, that impact their coping abilities and communication (e.g., future health care planning). The COPE+ intervention is a promising mental health and communication treatment for older adults with cancer and MCI, and their caregivers. The proposed study will conduct a pilot study to test a brief (6-week), tablet- based, personalized intervention that includes family caregivers, in this at-risk group.